P-selectin-Mediated Targeting of PI3K Nanomedicines to the Tumor Microenvironment

SUMMARY
Personalized medicine, based on the genomic context of a patient’s disease, has become a leading strategy to
treat cancer. However, despite the promising results from customized treatments, targeted therapies affect the
same signaling pathways in non-cancerous cells, often leading to dose-limiting, “on-target” toxicities. One such
example involves PI3K inhibitors. In head and neck squamous cell carcinoma (HNSCC), the 6th most common
cancer worldwide, 34%-56% of tumors harbor mutations or amplifications in PIK3CA, the gene coding for the
p110α subunit of PI3K. PI3Kα inhibitors carry a significant toxicity profile, however, that limits their therapeutic
window, specifically in patients who develop intractable hyperglycemia. Using a targeted drug delivery
approach, we have identified a strategy to address this need. The PI developed a new class of nanoparticles
targeted to P-selectin which allows the incorporation of a wide variety of therapeutic molecules, including
targeted therapies (Shamay, Sci Transl Med 2016). We built a collaborative research team that employed this
technology to target tumors expressing endothelial P-selectin, either at baseline or radiation-induced (Mizrachi,
Nat Commun 2017). The strategy effected a significantly improved therapeutic index and survival, while
minimizing the side effects of targeted therapeutics. Notably, we found that PI3K inhibitors, targeted using our
nanoparticle vehicle, resulted in prolonged pS6 inhibition and anti-tumor efficacy, while minimizing acute and
chronic effects of hyperglycemia. The objective of this project is to investigate, in the context of HNSCC, the
nanoparticle-mediated delivery of PI3K therapies via P-selectin, expressed spontaneously or induced by
radiation. This proposal’s goals are to understand the modulation of drug pharmacology, efficacy, toxicities,
interactions with HNSCC tumor microenvironment, and the impact of ionizing radiation on these parameters.
We plan to pursue the following specific aims: 1) Assess P-selectin-mediated targeting to the tumor
microenvironment. We will measure the localization of the nanoparticle and encapsulated drug in the tumor
microenvironment from the organ to cellular levels. 2) Enhance nanoparticle localization via radiation-induced
endothelial activation. Based on our understanding of radiation-induced expression of P-selectin, we
hypothesize that external beam radiation can increase localization of a P-selectin-targeted PI3K inhibitor in
disseminated tumors due to the increased availability of the target. 3) Assess efficacy of P-selectin-mediated
targeting of PI3K inhibitors. We will assess the relationship between drug delivery mechanism and treatment
response. We hypothesize: (i) that the P-selectin-based targeting will improve PI3K inhibitor-mediated efficacy
and apoptosis in tumors, (ii) that radiation may increase the relative efficacy of the inhibitor, (iii) that
nanoparticle-mediated P-selectin targeting will mitigate PI3K-mediated hyperglycemia, and (iv) that
nanoparticle-delivered therapeutic combinations will improve synergistic effects while attenuating toxicities that
arise from systemic administration of multiple inhibitors. The outcomes will inform IND and clinical studies.

Public health relevance
NARRATIVE This work proposes a new therapeutic strategy to address solid tumors in general and head and neck squamous cell carcinoma (HNSCC) in particular. HNSCC is the 6th most common cancer worldwide. The researchers propose to investigate the targeting of personalized therapy directly to the tumor environment and to gain an understanding of how this targeting changes the efficacy and toxicities of this therapy in HNSCC.